Quantitative proteome of the photoreceptor outer-inner segment junction

Retinal photoreceptors are specialized neurons responsible for detection and primary processing of the
information entering the eye in the form of light. These first steps of vision take place in the photoreceptor outer
segment, which contains proteins performing visual signal transduction. It is connected to the cell soma (or the
inner segment) through the connecting cilium, which serves as a trafficking route for the outer segment
proteins synthesized in the inner segment. The cellular structures immediately adjacent to the connecting
cilium are also engaged in performing critical photoreceptor functions. At the distal end of the connecting cilium
is the site of photoreceptor disc morphogenesis where several dozen new discs are formed on a daily basis to
sustain the ever-going process of outer segment renewal. At the proximal end of the connecting cilium, there
are structures forming a sorting gate that regulates the outer segment entry and exclusion of membrane
proteins. Defects in any of these processes have been implicated in a wide range of photoreceptor
degenerative diseases. Despite many proteins already being mapped to the connecting cilium and other parts
of the outer-inner segment junction using conventional biochemical and genetic approaches, our knowledge of
the protein composition of this cellular region remains far from complete, which hinders the progress in
elucidating the molecular mechanisms of protein trafficking, sorting, outer segment maintenance and disc
morphogenesis. The goal of this proposal is to reduce this knowledge gap by characterizing the unique
proteome of the photoreceptor outer-inner segment junction. In Aim 1, we will employ a cutting-edge
application of quantitative proteomics, called protein correlation profiling. Unlike traditional biochemical
techniques, this methodology allows analyzing the unique protein composition of subcellular structures that can
be enriched but not purified, as in the case of the connecting cilium and its adjacent regions. We will obtain thin
serial tangential sections through the outer-inner segment region of a frozen flat-mounted retina and
characterize the protein composition of these sections using label-free quantitative mass spectrometry. The
resulting protein distribution profiles will be compared to those of well-characterized connecting cilium markers.
Proteins distributed similarly to these markers will be considered as candidate unique components of the outer-
inner segment junction, and their localization will be verified using immunolocalization techniques. In Aim 2, we
will employ a novel, highly accurate approach of multiplex protein quantification to simultaneously determine
absolute amounts of large groups of previously known and newly identified proteins residing at this cellular
location. This analysis will suggest which proteins may exist within multi-subunit stoichiometric complexes
and/or specific subcellular structures, thereby facilitating uncovering their functional roles. The information
generated in this resource- and hypothesis-generating study will undoubtedly facilitate the efforts of many
laboratories addressing a broad array questions related to photoreceptor biology and disease.

Public health relevance
The connecting cilium and adjacent regions of the photoreceptor cell perform a spectrum of functions vitally important for our vision, ranging from protein sorting and trafficking to biogenesis of the light-capturing membranes. However, the limited knowledge of the molecular composition of this critical part of the cell impedes our ability to elucidate the underlying mechanisms. We propose to close this knowledge gap by identifying and quantifying unique protein components of this photoreceptor region, thereby facilitating the progress in our understanding photoreceptor biology and disease.